Origin, diversification and function of pancreatic cancer associated fibroblasts

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) is one of the top five deadliest cancers due to a lack of effective
treatment options. One hallmark of PDAC is the expansion of cancer associated fibroblasts (CAFs). CAFs play
critical and complex roles in PDAC microenvironment to modulate tumor progression and therapeutic response.
The long-term objective of my research program is to determine the cellular origin, heterogeneity and function of
CAFs in pancreatic cancer. To identify the tissue origin of CAFs in PDAC, I performed lineage tracing
experiments using genetically engineered mouse models. The splanchnic mesenchyme is a particular type of
mesenchyme adjacent to the pancreatic epithelium during fetal development. My studies demonstrated that the
splanchnic mesenchyme is the fetal origin of CAFs in PDAC (Han et al, Nat Commun, in press). In this current
proposal, I aim to further investigate whether splanchnic-derived CAFs maintain certain molecular signatures of
their fetal progenitors. The Hedgehog pathway is a critical paracrine signal between the epithelium and
mesenchyme during fetal development and is reactivated during tumorigenesis of the pancreas. The Hedgehog
signal modulates PDAC progression, but its downstream targets in CAFs have not been identified. My graduate
study showed that transcription factors FOXF1 and GATA6 are downstream targets of the Hedgehog pathway
in the fetal splanchnic mesenchyme. My preliminary studies suggested that these factors are also expressed in
PDAC CAFs in a regionally distinct pattern within the tumor microenvironment. In Aim 1, I will determine whether
FOXF1/GATA6 patterning in CAFs is regulated by the Hedgehog pathway activity. Hedgehog agonist or
antagonist will be utilized in in vitro cell or organoid culture and in vivo mouse models. In Aim 2, I will determine
the function of FOXF1+ CAFs and GATA6+ CAFs in PDAC by deleting these genes specifically in CAFs both in
vitro and in vivo as well as in patient correlation studies. The completion of this study will provide critical insights
in PDAC CAF biology, including novel cellular heterogeneity defined by selective persistence of fetal signatures
in coordination with the epithelium, and certain fetal signatures playing tumor-suppressing roles in a non-cell
autonomous manner. Ultimately, such knowledge in tumor microenvironment may reveal critical targets and
therapeutic avenues to inhibit tumor progression and prolong PDAC patient survival. I received rigorous training
in developmental biology during my graduate study. Four years ago, I started my training in cancer biology as a
postdoctoral fellow in the Hollings Cancer Center. During the K99 phase, I aim to further enhance my expertise
in pancreatic cancer research and to acquire several additional skills, which are essential to launch my
independent research program during the R00 phase. I aspire to draw from paradigms in both embryology and
oncology to develop novel perspectives and to tackle fundamental biological questions.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is one of the deadliest cancers and is characterized by an expansion of fibroblasts which modulate the tumor microenvironment. This proposal aims to elucidate molecular signatures and functions of cancer associated fibroblast subtypes in PDAC. This research will contribute to fundamental knowledge of PDAC biology, and may ultimately lead to design of more effective therapeutics for PDAC patients.